Predicting and Monitoring for Cardiac Toxicity in Pediatric AML

Abstract:
Children with acute myeloid leukemia (AML) receive the maximum cumulative anthracycline exposure
during frontline therapy (>440 mg/m2), an exposure that causes very well-described cardiac complications. The
importance of acute, short-term cardiotoxicity in pediatric AML has been described recently by our group using
Children’s Oncology Group (COG) clinical trial data. Specifically, nearly 40% of patients experienced left
ventricular systolic dysfunction (LVSD) warranting chemotherapy modifications, and 21% suffered LVSD
consistent with moderate to life-threatening cardiomyopathy or heart failure. Over 70% of LVSD was first
documented during frontline therapy and was associated with a 13% absolute decrease in overall survival
(OS). Notably, the decline in OS from early cardiotoxicity is larger than the improvement from any randomized
intervention reported to date in pediatric AML cooperative group trials. Despite this clinical impact, there are no
clinical prediction models for early chemotherapy associated cardiac toxicity. The cardiotoxicity prediction
models developed to date focus exclusively on long-term childhood cancer survivors due to the absence of a
sufficiently large and well-characterized de novo AML cohort. The variability in guidelines and clinical practice
is fertile ground for disparities in echo monitoring and identification of cardiac outcomes, yet the well described
disparities in survival outcomes by race/ethnicity in pediatric AML have not included analyses of echo
adherence or cardiac dysfunction.With this application, we propose to develop a highly unique dataset
including detailed demographic, clinical, genomic, treatment, and toxicity data, combined with longitudinal
indices of LV size, diastolic, and systolic function from all clinical surveillance echocardiograms for patients
enrolled on two COG AML trials, AAML0531 and AAML1031. With this unique data set, we will use novel,
sophisticated analytic methods to develop models that: (1) continually update predictions of early cardiotoxicity
risk during frontline therapy, (2) predict LV functional trajectories leading to persistent or worsening LVSD in
the early/moderate time window after AML therapy, and (3) compare cancer treatment outcomes (EFS and
OS) and detection of LVSD for three cardiotoxicity monitoring schedules with different echo frequencies in
pediatric AML patients. The first model should enable personalized chemotherapy modifications and earlier
initiation of cardiac-directed medications, thus improving survival outcomes. The second model should inform
more personalized, evidence-based recommendations for off-treatment cardiotoxicity surveillance, potentially
leading to improved adherence and reducing costs of unnecessary testing. The third analyses will provide a
data driven guidance for on-therapy echocardiogram monitoring for pediatric patients with AML.

Public health relevance
Project Narrative Although chemotherapy related cardiac toxicity is associated with decreased survival outcomes in children receiving treatment for acute myeloid leukemia (AML), there are no clinical prediction models for incident cardiac toxicity or trajectories of the progression or resolution of cardiac dysfunction. The well described disparities in survival outcomes by race and ethnicity in pediatric AML have not included analyses of echo monitoring adherence or subsequently identified cardiac dysfunction. This application seeks to address these knowledge gaps with following three specific aims: (1) Develop and validate dynamic prediction models for incident early chemotherapy associated LVSD, defined as ejection fraction (EF) ≤50% or fractional shortening (SF) ≤24%, in pediatric AML patients; (2) develop and validate prediction models for latent phenotypes defined by distinct trajectories of LV function based on longitudinal echo-derived measures of LVEF in pediatric AML patients, and (3) identify disparities in off-therapy echo monitoring, early incident chemotherapy associated LVSD, and evaluate their role as intermediates in disparities in survival outcomes.